CHOP Pediatric Center of Excellence in Nephrology

CENTER OVERVIEW PROJECT SUMMARY
With this renewal, the Pediatric Center of Excellence in Nephrology at the Children’s Hospital of
Philadelphia (CHOP PCEN) will continue to facilitate extensive collaborative research around the
causes, diagnoses, and treatment of childhood kidney diseases. Increasing efficiency and
effectiveness, the CHOP PCEN will continue its focus to break down barriers to clinical trials
implementation in our patients. In its initial four years of funding, the CHOP PCEN has partnered
with PEDSnet through the Learning Health System (LHS) Core to establish a national
interconnected, multi-institutional infrastructure focused on childhood kidney disease. The LHS
Core has extended the data science work of PEDSnet to establish an embedded Pediatric
Nephrology Data Resource that emphasizes data elements and data quality optimization central
to studies of kidney disease. In the next funding cycle, the LHS Core will provide expanded
services for comparative effectiveness and pragmatic trials in pediatric nephrology. Through the
addition of the Molecular Precision Nephrology (MPN) Core, we will facilitate identification of novel
targets to expand therapeutic options for children and youngadults with kidney disease. The MPN
Core is uniquely poised to address critical barriers to the clinical and research implementation of
molecular precision tools in pediatric nephrology. The Administrative Core facilitates consultation
with experts in study design and analysis to achieve appropriate inferences from observational
data, and in this proposal, to design comparative effectiveness studies and pragmatic clinical
trials. The Administrative Core will support the Opportunity Pool Pilot and Feasibility Program, the
Enrichment Program, and two Research Projects that apply innovative approaches to the data
resources of the LHS Core and NIDDK consortia (CKiD and CureGN) to address clinically
important evidence gaps. One project will examine comparative effectiveness of balanced fluids
versus normal saline to reduce the risk of acute and chronic kidney diseasein children with sepsis.
The second project will develop, test, and apply a novel class of marginal structural models to
estimate time-varying treatment effects on different types of recurrent time-to-event outcomes,
including proteinuria remission, infection-related acute care, and skeletal fracture. The PCEN will
build upon the strong foundation of pediatric nephrology research at CHOP and Johns Hopkins
University as well as successful collaborations with other pediatric nephrology centers and adult
nephrology colleagues at the University of Pennsylvania. We will amplify these interactions across
institutions to accelerate translation of discoveries into therapies for children and young adults
with kidney disease.

Public health relevance
CENTER OVERVIEW PROJECT NARRATIVE The Pediatric Center of Excellence in Nephrology at the Children’s Hospital of Philadelphia (CHOP PCEN) will continue to facilitate extensive collaborative research around the causes, diagnoses, and treatment of kidney diseases in children and break down barriers to clinical trials implementation. The CHOP PCEN will continue to partner with PEDSnet through the Learning Health System (LHS) Core leveraging the resources of a national interconnected, multi- institutional infrastructure focused on childhood kidney disease and establish a new core, the Molecular Precision Nephrology (MPN) Core to facilitate identification of novel molecular targets to expand therapeutic options for children with kidney disease. The Administrative Core will support the Enrichment Program and Opportunity Pool Pilot and Feasibility Program as well as two Research Projects that apply innovative approaches to the data resources of the LHS Core and NIDDK consortia.